Single-Molecule and Single-Cell Analysis of Transcription Factor-DNA Complexes

DESCRIPTION (provided by applicant): Cells make decisions all the time as part of their normal life cycles. These decisions range from the expression of metabolic preferences to choices critical to human health such as whether cells will enter a state of unchecked proliferation or express antibiotic resistance genes. The overarching goal of the work proposed here is to decipher the rules that manage cellular decisions and to subject models of the regulatory process to stringent experimental tests with the aim of developing a predictive understanding of the regulatory code. Though the kinds of models we develop can be applied to both prokaryotic and eukaryotic regulatory circuits, we are focusing first on bacteria in order to build up an entire suite of tools taking us from regulatory architecture discovery at basepair resolution all the way to the systematic quantitative determination of the input-output functions for these circuits. E. coli is one of the best understood of organisms. And yet, out of its more than four thousand genes, we know almost nothing about how half of them are regulated. The work proposed here is built around three main aims that together will result in a predictive picture of transcriptional regulation. The work in the first aim uses a method known as Sort-Seq that makes it possible to identify the constellation of binding sites for the transcription factors that control a given gene of interest. We will use this method as a tool both to design synthetic networks and as the basis of discovering the regulatory architectures for a number of important bacterial genes for which essentially nothing is known. With this regulatory information in hand, in the second aim, we will characterize the input-output response of regulatory elements whose architectures have been characterized using the Sort-Seq approach. Specifically, systematic experiments will be performed to test how variability in gene expression depends upon key parameters, such as the number of transcription factors and the strength of transcription factor binding sites. One of the most mysterious classes of regulatory network involves the binding of transcription factors at a distance from the genes they control. The third aim develops a mechanistic understanding of how these trans-acting factors control the promoter of interest. This analysis will be made using a combination of in vivo experiments and single-molecule measurements. The outcome of this work will be a robust framework permitting us to go all the way from regulatory architecture discovery with base pair resolution to the systematic quantitative determination of the input- output functions of generic regulatory architectures.

Public health relevance
PUBLIC HEALTH RELEVANCE: Transcriptional regulation is at the heart of processes in biology ranging from the formation of biofilms to differentiation and development. In its role as one of the central threads in regulatory biology, the study of transcription is relevant to biology and medicine alike. The work proposed here aims to construct a high-resolution and quantitative understanding of transcription in microbes in a way that will have applications from synthetic biology to the study of pathogens. __SpecificAimsTextDelimiter__ Specific Aims The long-term aim of research in my group is to develop a predictive and quantitative understanding of tran- scriptional regulation. In the current project period, our systematic dissection of bacterial transcription for several key case studies provided a quantitative picture of how architectural and molecular parameters govern gene expression. These studies revealed a number of surprises showing that the conventional picture of how these parameters influence transcriptional regulation falls short both qualitatively and quantitatively. Here, we build upon our previous successes with quantitative models and corresponding precision measurements by invoking sequencing and information theory to provide a high-throughput, quantitative, base-pair resolution view of the regulatory code in bacteria, setting the stage for the use of this approach in other organisms. In the next project period, we propose to build on our earlier results in three primary directions: Specific aim 1. Discover regulatory architectures at base-pair resolution using mutagenesis, expression and sequencing (Sort-Seq). Many of the best understood examples of transcriptional regulation occur in bacteria. However, even in prokary- otes, our understanding is woefully inadequate. Databases of regulatory networks such as RegulonDB and EcoCyc reveal that nearly half of the genes even in E. coli are devoid of any data on the constellation of tran- scription factor binding sites and the molecular identities of the transcription factors that control these genes. For most other organisms, the situation is even worse. As part of our goal of developing a quantitative and predictive understanding of transcription, we will use a recently developed technique called Sort-Seq to characterize the regulatory modules of several poorly characterized bacterial promoters. The outcome of this work will be a map with base-pair resolution of the identity and position of transcription factor binding sites as well as the identity of the relevant transcription factors. Not only will these efforts elucidate the regulation of a class of important bacterial genes, but it will also lay the groundwork for using these techniques much more broadly. In addition, the determination of these regulatory motifs will serve as the basis for the characterization of the input-output response of these architectures in Aim 2. Specific aim 2. Quantitatively tune the parameters characterizing bacterial regulatory networks deter- mined using Sort-Seq to measure their input-output functions. For each of the regulatory networks characterized in Aim 1, the level of gene expression can be systematically tuned by altering a number of architectural and molecular parameters. Key knobs which elicit distinct biological responses include: transcription factor copy number, gene copy number, promoter strength, transcription factor binding-site strength, operator position, ribosomal binding-site strength, and the length and sequence of the DNA fragments linking promoters to trans-regulatory binding sites. Theoretical predictions of how the mean level of expression and the cell-to-cell variability of gene expression are altered by these parameters will be subjected to exacting experimental scrutiny by tuning these same architectural and molecular parameters systematically and measuring the resulting level of expression at the single-cell level. In particular, we will first complete our quantitative characterization of model promoters, where the promoter architecture itself is designed using the results of a Sort-Seq analysis. This will be followed by several far reaching case studies, including regulation of mechanosensitive channels in E. coli, about which basically nothing is known, and the regulatory response of Pseudomonas aeuruginosa to iron, which involves the coupling of regulatory networks and the expansion of our methods to new organisms. Specific aim 3. Systematic dissection of regulatory motifs involving long-range interactions of transcrip- tion factors. Action at a distance in transcriptional regulation is the rule rather than the exception in prokaryotes and eukary- otes alike. For those promoter architectures exhibiting this kind of regulation, transcription factors bind at sites that are not in direct contact with the basal transcription apparatus. Using the Sort-Seq methods developed in Aim 1, we will examine architectures featuring long-distance regulation in order to find those sequences that are particularly effective (or not) in repressing the gene of interest and to understand how these sequences drive interactions with the architectural proteins decorating bacterial genomes. These same sequences will then be considered in the in vitro setting where we will carry out high-throughput single-molecule measurements. By linking our Sort-Seq analysis with these high-throughput single-molecule methods we will greatly improve our understanding of the regulatory code for long distance regulation.